FDACS-Maintenance AFRPS w/Optional Coordinated PC Regulatory Activities

Project Summary
Overall
Florida Department of Agriculture and Consumer Services (FDACS)
Maintenance AFRPS w/Optional Coordinated PC Regulatory Activities
PAR-20-132
Division of Agricultural Environmental Services (AES)
Proposal to FDA for Participation in Development and Maintenance of the Animal
Feed Regulatory Program Standards with Optional Coordinated Preventive
Control Regulatory Activities and Capacity Building (U18) Clinical Trial Not
Allowed
Project Date: September 01, 2020 – August 31, 2025
The Florida Department of Agriculture and Consumer Services is requesting funding to
enhance the infrastructure and effectiveness of Florida's Feed Safety monitoring and
enforcement programs through participation in AFRPS Maintenance Phase Track and
Optional PC Capacity Building PAR-20-132 for the activity tracks specified below.
Year AFRPS Maintenance PC Funding Option
Total Amount
Requested
1 $225,000 $300,000 $525,000
2 $225,000 $300,000 $525,000
3 $225,000 $300,000 $525,000
4 $225,000 $300,000 $525,000
5 $225,000 $300,000 $525,000

Public health relevance
Project Narrative Overall Florida Department of Agriculture and Consumer Services (FDACS) Maintenance AFRPS w/Optional Coordinated PC Regulatory Activities PAR-20-132 Division of Agricultural Environmental Services (AES) Proposal to FDA for Participation in Development and Maintenance of the Animal Feed Regulatory Program Standards with Optional Coordinated Preventive Control Regulatory Activities and Capacity Building (U18) Clinical Trial Not Allowed The Florida Department of Agriculture and Consumer Services (FDACS) is requesting funding to enhance the infrastructure and effectiveness of Florida’s Feed Safety monitoring and enforcement programs through participation in Implementation of the Maintenance AFRPS w/Optional Coordinated PC Regulatory Activities PAR-20-132.